DETECTION AND ANALYSIS OF H-2 VARIANT CELL LINES FROM MURINE T CELL LYMPHOMAS

Various lines of the S-49 T cell lymphoma of BALB/c origin are being studied for the expression of H-2 antigens. Normal BALB/c lymphocytes express H-2Kd, H-2Dd, and H-2Dd antigens. We have found that the five lines of the S-49 lymphoma thusfar studied do not express all of these cell surface H-2 antigens. The patterns of expression of H-2 antigens using these cell targets for: (a) antibody and complement; and (b) cytotoxic T lymphocytes (CTL) exhibit four different patterns of H-2d expression in the five lines tested. This system may be of value for investigating regulation of expression of major histocompatibility complex (MHC) antigens, and raises the possibility of a relatively high rate of modulation of these antigens among tumor cell lines of the same origin. No progress was made in this project during the past year. Due to time constraints, other projects have taken priority over this project. Although we continue to provide Dr. Hansen with cell lines from this project, we are not currently working on this project.